Pathogenicity of memory Th17 cells in chronic autoimmune uveitis

PROJECT SUMMARY / ABSTRACT
Chronic autoimmune uveitis is often a treatment-resistant disease, leading to irreversible vision loss in a
significant number of patients thus affected. With particularly high prevalence in the working-age population,
it accounts for 10-15% of legal blindness in the US, and adds a substantial socio-economic burden due to
consequent healthcare costs and productivity loss, estimated to be close to that of diabetic retinopathy.
The preponderance of previous studies investigating autoimmune uveitis have focused on the acute
stage of the disease using the popular murine models of acute uveitis, which in fact uncommonly leads to
severe vision loss in humans in contrast to chronic uveitis. Thus, there is a major deficiency in our current
understanding of the precise pathogenic mechanisms in chronic autoimmune uveitis. This deficiency has
been associated with the recently unexpected failure of several clinical trials, which had promising
translational potential as a therapeutic strategy from animals with acute uveitis to human patients with
chronic uveitis. Our laboratory has now developed and validated a mouse model of chronic autoimmune
uveitis (CAU) in wild-type animals, which presents with a slow-onset, progressive disease course for an
observed duration of 3 months, replicating the clinical features of chronic progressive uveitis observed in
humans. We hope to use this animal model to develop a deeper understanding of the immunopathogenesis
of uveitis during the chronic stage, and thus provide a solid foundation for prioritizing the development of
new targeted treatment in human patients.
Our preliminary work in the CAU model has detected a prominent memory T helper-17 cells (mTh17),
and this unique cell population from CAU has demonstrated vigorous responses to uveitogenic antigen
stimulation in vitro. Memory T cells are antigen-experienced, long-lived T lymphocytes mediating
immunological memory. Increasing evidence has demonstrated that immunological memory plays a critical
role in autoimmune disorders and chronic inflammation. We thus hypothesize that memory Th17 cells are
specific uveitogenic effectors and mediate the chronic disease course of uveitis. The principal objectives of
this project are to (i) precisely characterize the phenotype and function of mTh17 in CAU; and (ii) determine
the function of mTh17 in the maintenance of chronicity of uveitis. To achieve these objectives, two specific
aims have been developed: Aim 1: Are mTh17 featured as `effector memory' T cells capable of inducing
uveitis? And Aim 2: Will supplementation or depletion of mTh17 affect the disease course in established
acute or chronic uveitis, respectively? Successful completion of this project will provide a framework for the
development of novel therapeutic approaches precisely targeting the underlying cause of disease chronicity
– a process resistant to the currently available treatment and leading to severe visual impairment.

Public health relevance
PROJECT NARRATIVE Chronic autoimmune uveitis is a prevalent intraocular inflammatory disease, with the potential of causing severe visual impairment and blindness. The clinical management of patients with chronic uveitis is challenging due to the limited availability of efficacious treatments, primarily due to our poor understanding in the immunopathogenesis of this condition, particularly the mechanisms mediating disease chronicity. We propose to determine the pathogenic roles of immunological memory in actively mediating chronic autoimmune uveitis, with the objective of improving our understanding of disease pathogenesis and facilitating future translational studies.